The role of the precursor HIV-1 protease in drug resistance.

Project Abstract
This project aims to determine whether the precursor HIV-1 protease (PR) plays an important role in the
development of drug resistance to protease inhibitors (PIs). The precursor PR dimer is far less susceptible to
inhibition by PIs than the mature PR dimer, leading to the hypothesis that drug resistance mutations may
evolve through the relative resistance of the precursor PR. Using innovative techniques ‘locking’ PR in the
precursor configuration, we have unexpectedly found that viruses can mature, fuse with target cells, and
replicate without formation of mature PR, providing a clear path through which drug resistance can evolve.
Aim 1: Assess how mutations within PR or the p6*-PR cleavage site influence dimerization and activity of the
precursor and mature PR enzymes.
Aim 2: Assess whether PI resistance that develops without canonical mutations in PR alters dimerization and
precursor or mature PR function.
Aim 3: Perform in vitro viral propagation experiments to better understand how the precursor PR contributes to
drug resistance.

Public health relevance
Project Narrative This project seeks to determine whether drug resistance to protease inhibitors (PIs) develops through the activity of the precursor HIV-1 protease (PR). Using innovative techniques ‘locking’ PR in the precursor configuration, we have found evidence supporting the concept that viruses can replicate and evolve DRMs without requiring the activity of the mature PR. This project aims to provide further evidence supporting or rejecting the hypothesis that drug resistance to PIs evolves via the activity the precursor PR, which, if correct, would have important implications for reducing resistance to this class of antiretroviral drug.